Quantification of Tics in Tourette Syndrome

PROJECT SUMMARY/ABSTRACT
Tourette Syndrome (TS) is a chronic, childhood-onset neurodevelopmental disorder that affects 1-3% of people
and is associated with adverse functional impacts. TS is characterized by tics, which are involuntary, repetitive
movements and vocalizations. A current challenge in clinical care for TS is the lack of objective, quantitative,
scalable tools to measure tics for the purposes of diagnosis and symptom severity monitoring. The overall
objective of the proposed study is to use video-based methods in a large, diverse community sample to inform
quantitative and automated phenotyping of tics. This study builds on prior work, including: 1) video-based
observational methods with trained human raters to quantify tics for research purposes, 2) computer vision and
machine learning techniques for movement analysis and medical diagnostic aids, and 3) preliminary data
indicating supervised learning methods can be used to automate detection of eye tics with high accuracy. In
Aim 1, videos and clinical data from N = 1,000 individuals with tics will be collected using remote and
internet-based methods. A deep phenotyping approach will be used to quantitatively describe the phenotypic
spectrum of observable motor and vocal tics, empirically derive tic severity benchmarks, and identify patient
subgroups. In Aim 2, our computer vision team will apply supervised machine learning methods to Aim 1 data
to create an algorithm capable of detecting the most common tics. Aim 3 will prospectively test the Aim 2
algorithm in N = 60 patients who completed TS treatment in a separate clinical trial to establish the algorithm’s
sensitivity to change and convergent validity with current gold-standard tic severity measurement. This project
will enable us, for the first time, to quantify the spectrum of observable tics in a large community sample,
knowledge that will have immediate clinical relevance for diagnostic decision making and patient education.
Aim 2 will yield a computer algorithm capable of autonomously quantifying the most common motor tics, a
critical next step toward developing accurate, clinically valid, and scalable assessments for tic screening,
diagnosis, treatment decision making, and symptom quantification in clinical trials.

Public health relevance
PROJECT NARRATIVE Tourette Syndrome (TS) is a chronic neurodevelopmental disorder that is characterized by tics, which are involuntary, repetitive movements and vocalizations. A major limitation in TS healthcare is the lack of clinical assessment measures to objectively diagnose and quantify tics and their severity, one reason that many individuals with TS go unrecognized or experience long delays in diagnosis and treatment access. In this study, we will create a large video and questionnaire dataset of N = 1,000 individuals with tics, code the videos for tic symptoms using human raters to better understand the spectrum of symptoms, and use the coded videos to train a computer algorithm to automatically detect and quantify tics.